Molecular imaging of viral infections

Progress:
HIV project: We are in the stage of optimizing our animal model of Gp120 expressing HEK293 tumors implanted in nude mice in comparison to wild type tumors. We have validated and labeled multiple nanobodies against GP120 with 18F and started PET imaging. Early results are encouraging and we are currently optimizing site specific binding. Results are pending.

Ebola and other high consequence viral infection: We are collaborating with the Integrated research facility on multiple studies evaluating Nipah, Lassa, Marburg, Covid-19 and Ebola infections.

Sars-Cov-2 project: We have finished our experiments and are currently writing the manuscript.